Advancing a Prognostic and Monitoring Biomarker of Neutrophil-driven Secondary Brain Injury in Spontaneous Intracerebral Hemorrhage for Neurotherapeutics Development

Summary:
Spontaneous intracerebral hemorrhage (sICH) is the stroke subtype with the highest mortality and disability, and
remains without effective pharmacotherapy to improve outcomes. To advance sICH neurotherapeutic
development, peripherally accessible biomarkers are needed that are 1] prognostic for progressive non-resolving
neutrophil-driven secondary brain injury (ND-2°BI), and/or 2] able to monitor increase or decrease of ND-2°BI in
sICH patients. However, to date, no neutrophil biomarker has been validated. Addressing this knowledge gap,
we have identified a “rogue” CD11b+ neutrophil subset, expressing the pro-survival dual endothelin-1/signal
peptide receptor, DEspR+CD11b+ neutrophil or DEspR+[N] subset, whose levels correlate with perihematomal
edema (PHE) volume and 90d modified Rankin Scale (mRS) score. Data validate biomarker ‘context of use’ that
DEspR+[N] levels are a potential prognostic biomarker in sICH to better stratify patients in clinical trials, and/or
a potential monitoring biomarker for tracking ongoing ND-2°BI. In response to PAR-22-089, we propose testing
“Fit-for-purpose” with FDA-required biomarker milestones in a primarily underserved and diverse patient cohort
of hypertensive, supratentorial deep sICH, with no anticoagulant therapy or immunological deficiencies. R61-
Aim1. To define and validate a standardized ‘universal protocol’ to detect DEspR+[N] levels as potential
biomarker in sICH patient samples by flow cytometry, we will determine the best sampling procedure and flow
cytometry detection requirements, and validate flow cytometry results with quantitative immunofluorescence-
cytology results. The ‘universal protocol’ should attain 1] <10% intra-assay variation, and 2] <10% false positive
and false negative rates. R61-Aim 2. To validate biomarker performance as a systemic indicator of ND-2BI, we
will A] test if the DEspR+[N] subset comprises the majority of pro-injury NET-forming [Ns], anti-resolution PDL1+
neutrophils, and PDL1+ NET-forming neutrophils in sICH patient whole blood samples, and B] test association
with cell-injury markers: S100A8/A9 (BBB endothelial injury), GFAP (BBB astrocyte endfeet injury), Nfl (white
matter injury). R61-Aim 3. To ascertain robustness of DEspR+[N] as a biomarker of ND-2BI, we will identify the
optimal unit measure by comparing 3 units for correlation with peak PHE volume in sICH patients: a] actual
DEspR+[N] levels, b] DEspR+[N]: summation delta increase/decrease in DEspR+[N], and c] DEspR+[N]/IPH-
vol or ICH score ratio: DEspR+[N] level normalized to d1 IPH vol or ICH score. Significant largest effect size
correlation and robust high/low threshold levels will define the best unit. R33-Aim 1. To obtain proof-of-concept
(POC) as a prognostic biomarker in sICH patients (n=72), we will assess the high/low thresholds for 30d mortality
of DEspR+[N] levels for sensitivity, specificity and receiver operating curve area under the curve. R33-Aim 2. To
obtain POC as a monitoring biomarker, we will determine whether best unit measure of DEspR+[N] levels 1]
predicts 90d mRS, and 2] mediates worse 90d mRS in high ICH score patients. Impact: Completion will identify
a universal protocol for measuring, and qualify DEspR+[N] levels for Analytics Validation as ND-2°BI biomarker.

Public health relevance
Narrative: There is unmet need for mechanism-based prognostic and monitoring biomarkers of neutrophil-driven secondary brain injury (ND-2BI) in spontaneous intracerebral hemorrhage (sICH), as non-resolving ND-2BI manifesting as progressive brain edema is the major cause of high mortality and disability in sICH and remains without effective pharmacotherapy. As specified in PAR 22-089, this R61/R33 proposes to fulfill required first steps towards formally determining whether levels of DEspR+CD11b+ neutrophil-subset (DEspR+[N]) qualify as potential prognostic biomarker for patient enrichment in clinical trials and/or as a potential monitoring biomarker for treatment guidance in clinical trials: step-1] validate a universal reliable detection protocol, step-2] verify the scientific basis and step-3] test proof-of-concept in sICH patient samples ex vivo. Validation of DEspR+[N] subset levels as a prognostic and/or monitoring biomarker for non-resolving ND-2BI will be critical for neurotherapeutic development in sICH, and paves the way for forthcoming formal FDA-compliant, Analytics Validation and Clinical Validation studies in multi-center studies.